Identifying Novel Radiation Sensitizers in Cervical Cancer

PROJECT SUMMARY/ABSTRACT
Per the additional NCI guidelines for PA-21-01, the parent grant abstract is uploaded as part of the six-page requirement
for Research, Mentoring, and Career Development Plan.

Public health relevance
PROJECT NARRATIVE Project Narrative is not requested. This is an NCI Diversity Supplement to Dr. Lauren Colbert’s grant (R21CA277332), titled, Identifying Novel Radiation Sensitizers in Cervical Cancer.